Pharmacological Targeting of Tau Aggregates for Autophagic Removal in Alzheimer's Disease

In the past year, we have performed drug screening to identify small molecule ligands of our protein of interest and validated binding compounds and determined the binding site of hit compounds. This compound binding site has been corroborated in structure-activity relationship and mutagenesis experiments. We have also begun synthesizing compounds off-DNA identified in our screens and validated their binding affinity. In the next period, we will move into cellular models to test autophagy induction to further validate our methods and continue to test novel binding compounds identified in our screen.